Generation of Pan-reactive Antibody and Cytokine Reagents for Immunologic Analysis of Bats

ABSTRACT
Understanding the immune response in bats can aid in the response to viral outbreaks and other diseases, but
the bat research community suffers from a scarcity of immunologic research reagents. The remarkably high
divergence among bat species makes the development of cross-reactive MAbs and cytokine reagents
especially difficult. However, key residues within each protein form conserved epitopes that define the
fundamental structure and function of that protein, so isolating MAbs that recognize these conserved epitopes
provides an opportunity to generate MAbs that are reactive against most or all bat species (“pan-reactive”). Our
goal in this project is to develop MAbs against the most important immune targets that are cross-reactive
against nearly every bat species and characterized for every major research application, and an array of
cytokines that can be used across bat species.

Public health relevance
PROJECT NARRATIVE The significance of the proposed work is the generation of the highest quality and most broadly applicable MAbs and cytokine reagents for the study of the immune response in diverse species of bats.